Investigation of the preadipocyte primary cilia signalosome

Consequences associated with obesity can be miƟgated by shiŌing adipose Ɵssue expansion from hypertrophic to
hyperplasƟc expansion; the former increases overall size of exisƟng adipocytes and correlates with increased
inﬂammaƟon, insulin insensiƟvity, and ﬁbrosis, while the laƩer diﬀerenƟates new adipocytes from resident
preadipocytes through adipogenesis. Remedying the expansion of our adipose Ɵssue to favor healthier hyperplasƟc
expansion is of the upmost importance to combat the obesity epidemic, as western diets high in fat and carbohydrates
have shown to shiŌ the balance of fat expansion to the more consequenƟal hypertrophic expansion. All preadipocytes
have primary cilia, which are criƟcal for their diﬀerenƟaƟon into mature adipocytes. These organelles are typically rich in
signaling components, speciﬁcally G protein‐coupled receptors (GPCRs), though liƩle is known about ciliary protein
composiƟon in preadipocytes. Thus far only one receptor has been discovered in the cilium of preadipocytes, and its
acƟvaƟon increases ciliary cAMP and subsequent adipogenesis. Increases in cellular cAMP are necessary for ex vivo
adipogenesis, but it is unknown what role compartmentalized ciliary cAMP has in adipogenesis, though ciliary cAMP in
other cell types has been shown to have diﬀerenƟal funcƟons than whole cell cAMP. I hypothesize that cAMP in the
cilium is necessary and suﬃcient to induce adipogenesis in preadipocytes, and that a suite of ciliary GPCRs acts to
inﬂuence this process in a cilia‐dependent manner. My ﬁrst aim will deﬁne the role of ciliary cAMP in adipogenesis, using
chemogeneƟc and optogeneƟc tools to control the generaƟon or depleƟon of ciliary cAMP during adipogenesis to deﬁne
its suﬃciency and necessity in preadipocyte diﬀerenƟaƟon. My second aim will idenƟfy GPCRs that localize to
preadipocyte cilia and invesƟgate their physiological roles in adipose expansion and prevalence in healthy versus
unhealthy adipose Ɵssues.
This work will be conducted at the University of Utah under the guidance of my sponsor, Dr. Keren Hilgendorf, and co‐
sponsor, Dr. Jeremy Reiter, both of whom specialize in ciliary signaling. My thesis commiƩee is composed of
interdisciplinary researchers with a range of specialƟes all pertaining to diﬀerent porƟons of this proposal, such adipose
Ɵssue, signaling metabolites, GPCRs, and primary cilia signaling. Together, these mentors will provide expert guidance in
all facets of this project. In addiƟon, this project will be supported by the work of mulƟple university core faciliƟes,
including those that oﬀer services in cellular microscopy, ﬂow cytometry, mass spectrometry, and metabolomics. These
faciliƟes oﬀer excellent support and training services to facilitate my growth as a researcher. The training plan presented
was developed to ulƟmately prepare me for a future in academia as an independent researcher in the ﬁeld of ciliary
signaling and cell fate determinaƟon. In addiƟon to the technical skills this project will provide, it will also further my
development as a mentor and teacher through university‐supported training programs and laboratory opportuniƟes. Dr.
Hilgendorf has fostered a supporƟve research environment that encourages scienƟﬁc exploraƟon and my development
as a researcher. She has demonstrated dedicaƟon to my training and catered her mentorship to reﬂect my career goals.

Public health relevance
Project Narrative Primary cilia are signaling organelles present on nearly all stem and progenitor cells throughout the body that regulate cell fate, including the differentiation of preadipocytes into mature, fat storing adipocytes through adipogenesis. It is unclear how the cilium regulates this process, though recent discoveries highlight the only described ciliary G protein-coupled receptor drives adipogenesis in a cilia-dependent manner by increasing ciliary cAMP. This proposal will investigate the necessity and sufficiency of ciliary cAMP in the adipogenic process, as well as identify additional adipogenesis-modulating G protein-coupled receptors that localize to the preadipocyte cilium.